Glypicans in Bacterial Lung Infection

ABSTRACT
The major goal of this project is to understand how glypicans protect against bacterial lung infection by
coordinating a cellular defense mechanism that promotes bacterial clearance and inhibits bacterial invasion.
Pathogens use all tricks available to survive in the hostile host environment. Many pathogens bind to host
extracellular matrix (ECM) components and their receptors for their attachment, invasion and immune evasion,
suggesting that normal functions of the ECM are exploited for pathogenesis. However, while both host cells
and microbes are known to change their phenotypes and adapt to the artificial environment when cultured in
vitro, the current paradigm that the host ECM promotes infection as attachment and invasion receptors is
based predominately on data from in vitro systems. Furthermore, while the ability of the ECM to promote
pathogenesis has received much of the attention, potential beneficial functions of ECM components in
infections have been largely ignored. The abundant expression of ECM components and their receptors at
sites where pathogens frequently encounter the host, such as at the cell surface and subepithelial
compartments, suggests that certain ECM components may actually function in host defense. Glypicans, of
which there are 6 members in mammals, comprise a major family of cell surface heparan sulfate
proteoglycans, that function as receptors for morphogens, growth factors, cytokines/chemokines, and ECM
components, among other heparin/heparan sulfate-binding proteins. We found in preliminary studies that
glypican-4 null (Gpc4-/-) mice are significantly hypersusceptible to Staphylococcus aureus lung infection,
suggesting that Gpc4 protects against S. aureus pathogenesis. S. aureus is a major human pathogen and it
has a unique ability to infect virtually every tissue and organ system, including the lung. Our studies suggested
that Gpc4 provides protection against S. aureus lung infection via 2 distinct mechanisms: a neutrophil-
dependent and a neutrophil-independent mechanism in which Gpc4 inhibits S. aureus invasion into host cells.
This proposal will establish the importance of these previously unknown mechanisms and define their
molecular and cellular details in 3 Specific Aims. Aim 1 will determine how glypicans regulate early neutrophil
recruitment in bacterial infection. Aim 2 will define how glypicans inhibit bacterial entry of host cells, and Aim 3
will elucidate how bacteria counteract defense mechanisms mediated by glypicans.

Public health relevance
Bacterial pneumonia is a leading cause of death in the US and worldwide. Furthermore bacterial pneumonia is one of the most common causes of ARDS, a lung disease also associated with high morbidity and mortality, and bacterial co-infection is known to significantly increase mortality in patients infected with influenza. This project will investigate how one of our own molecules called glypican protects against Staphylococcus aureus pneumonia by promoting the early clearance of bacteria and preventing bacterial invasion of host cells in the lung. The proposed studies will generate new scientific information and identify new therapeutic targets for bacterial pneumonia.